Targeting HER2-low breast cancer with 17p loss

Project Abstract
HER2 overexpression is a powerful prognostic marker in node-positive patients with breast cancer.
Immunohistochemical (IHC) staining is the most widely used approach in the clinic for scoring HER2 status as
positive (3+), equivocal (2+), and negative (0 or 1+). Breast tumors with low levels of HER2 (1+ or 2+) are not
considered as positive for HER2 overexpression and such tumors do not well respond to HER2-targeted agents
anti-HER2 antibody (trastuzumab) and ado-trastuzumab emtansine (T-DM1). Due to their genetic diversity and
clinical heterogeneity, the therapeutic challenges for HER2-low breast cancer are the paucity of actionable
targets and lack of targeted therapies. We found that heterozygous deletion of chromosome 17p (17p loss) is
the most prevalent event in breast cancer (56%) as well as in TNBC (53%). Within the 17p deletion region is
the tumor suppressor TP53 (encoding p53), whose deletion or mutation is known as a primary tumorigenic driver.
Our recent study identified POLR2A in the TP53-neighboring region as a collateral vulnerability target in the
TNBC tumors with 17p loss, suggesting that inhibition of POLR2A may be a precision therapy approach. To
accelerate the translational development of our important finding, we are developing antibody-drug conjugates
(ADC) with α-amanitin (POLR2A inhibitor) as a warhead. This approach inhibits the specific uptake of α-amanitin
into hepatocytes and increases tumor-specific targeting using tumor-specific monoclonal antibodies.
In this project, we will first develop α-amanitin-conjugated trastuzumab (T-Ama) and test their efficacy in
treating 17ploss TNBC tumors with low levels of HER2. Second, we will determine how the 17p loss leads to
reduced T cell infiltration and cytotoxicity, thereby leads to immune evasion of the TNBC tumor. To determine
the underlying molecular mechanism, we will examine how the 17p loss negatively impacts tumor antigen
presentation and tumor immune response in TNBC. Finally, we will determine the efficacy of T-Ama as a single
agent or in combination with immune checkpoint blockade in treating TNBC with 17p loss.

Public health relevance
Project Narrative-Relevance to Public Health Chromosome 17p loss is a frequent genomic event in human breast cancer. We propose to develop a novel antibody-drug conjugate to precisely target the genomic defects in human HER2-low breast cancer. This research will integrate cancer genomics into precision medicine to fuel exciting translational development in breast cancer immunotherapy.